MiRNA Expression in Neuroblastoma

[unreadable] DESCRIPTION (provided by applicant): Neuroblastoma (NBL) presently accounts for 15% of all pediatric cancer deaths, and although numerous recurrent large-scale chromosomal imbalances have been identified in these tumors, some of which correlate with poor prognosis, the genes and genetic pathways affected by these alterations have largely remained elusive. The identification of new biological targets that contribute to the aggressive pathogenecity of this disease, along with the development of reagents that will interfere with the function of these targets, is a necessary prerequisite for improving patient survival. My laboratory has recently demonstrated in published pilot studies that many miRNA loci are differentially expressed in favorable and unfavorable NBL subtypes, and that ectopic over-expression of some loci can induce a caspase mediated apoptotic pathway. We also have shown that expression of some miRNA loci are highly altered in NBL cell lines following exposure to retinoic acid or the histone deacetylase inhibitor trichostatin A (TSA), agents which induce differentiation or apoptosis. Thus, the central hypothesis of this grant application, that the dysregulation of numerous miRNA sequences contribute to the aggressive pathogenicity of NBL, is firmly supported by our published preliminary studies. We plan to carry out the following specific aims: 1) extend our miRNA expression profiling studies to include a larger set of loci and a larger, more representative set of primary NBL tumors, along with profiling of cell lines undergoing differentiaiton or apoptosis in order identify candidate loci for functional testing and to evaluate the utility of miRNA expression for classifying tumors; 2) test the hypothesis that chromosomal imbalances significantly contribute to the dysregulation of miRNA expression in NBL; 3) perform functional studies on the biological effects of forced over or under-expression of miRNA loci in NBL cell lines; 4) validate miRNAs that target MYCN or upstream regulators of MYCN, allowing us to identify naturally occurring miRNAs capable of suppressing MYCN activity and 5) identify miRNAs that are directly regulated by MYCN which may be involved with apoptotic or differentiation pathways. The completion of these specific aims is expected to fill in many gaps in our knowledge on the role of miRNA dysregulation in NBL pathogenesis and lead to the identification of targets for potential therapeutic intervention. Neuroblastoma (NBL) presently accounts for 15% of all pediatric cancer deaths, yet the genes and genetic pathways that contribute to the aggressive pathogenecity of this disease have remained largely elusive. This project seeks to identify novel biological targets that contribute to neuroblastoma pathogenesis. The identification of such targets, along with the development of reagents that will interfere with their function, is a necessary prerequisite for improving patient survival. [unreadable] [unreadable] [unreadable]